Enhancing our understanding of intercellular communication to achieve programmable regeneration

PROJECT SUMMARY
The capacity for tissues and organs to heal and regenerate in response to injury has set the
stage for regenerative medicine, making numerous procedures possible, including the
generation of in vitro organ culture and transplantation. While this technology holds great
promise for the future of medicine, the full translation of regenerative biology into clinical
settings has been limited by a lack of mechanistic understanding underlying how different
regenerative outcomes are achieved. Specifically, the endogenous and exogenous signals that
determine in vitro cellular organization during regeneration and ultimately, coordinate successful
versus failed transplantation and de novo coordination with host tissues remains elusive. To fill
this knowledge gap, this proposal uses a model plant system that exhibits exceptional
regenerative capacities to advance our understanding of how intercellular communication
coordinates with endogenous cellular signaling to direct specific regenerative trajectories. This
system will be used to gain mechanistic insight into the intercellular interactions that shape
diverse regenerative potentials, by (1) mapping the cellular and developmental trajectories that
lead to different regenerative outcomes, (2) exploring the role of intercellular signaling in
shaping these regenerative paths, and (3) testing the extent to which gene regulatory circuits
can be perturbed to break and rebuild intercellular coordination during regeneration. In addition,
the potential for programmable regenerative engineering to produce predictive regenerative
outcomes and rescue tissue rejection during incompatible grafting will be tested through the
quantitative design of cellular implants. Taken together, this proposed research will not only
provide basic insights into regenerative cell biology, but also open up to the development of truly
synthetic environmental conditions that can robustly recreate targeted regenerative outcomes.

Public health relevance
PROJECT NARRATIVE The inherent capacity of organisms to regenerate in response to wounding has set the stage for regenerative medicine. While this technology holds great promise, it is currently limited by a lack of mechanistic understanding regarding how different regenerative outcomes are shaped by intercellular signaling. This project uses the profound regenerative capacity of plant systems to identify the mechanisms of intercellular communication that shape divergent regenerative outcomes.